Project 2: Genetics and Population Structure

Project 2: Genomics and Bioinformatics
Abstract
The main aim of this project is to assess, enhance and develop bioinformatics capacity and tools for genome
analysis in African populations and generate insights from the data that will be generated from AWI-Gen Phase
1 and Phase 2. In AWI-Gen Phase 1 we have characterized ethno-linguistic diversity in our four participating
countries and six collection sites (Table 1). Sixty whole genomes were sequenced (high coverage) from the
two West African populations (26 Kaseena from Ghana and 34 Mossi from Ghana and Burkina Faso
respectively). We are in the process of generating WGS data (mixture of high and low coverage) for 275 more
individuals (Table 2) that will enable us to have all the other major ethno-linguistic groups in our study
represented by WGS data. In the AWI-Gen Phase 2, we plan to use these data to estimate the level of genetic
diversity that accompanies the ethno-linguistic diversity across all our centers. WGS data will provide us with
insights into the genetic diversity in these geographic regions that are highly under-represented in the existing
genomic datasets. In addition it will provide us an opportunity to assess the quality of genotyping achieved by
the H3African SNP array, which is enriched for common African population variation and will also provide an
immensely valuable resource for imputation. Moreover, the WGS data, together with the genome-wide SNP
data from the H3Africa array on our ~12,000 participants will enable us to investigate to what extent the
existing genetic sub-structure might impact the association signals and the predicted risk levels in various
groups. We also plan to perform an in-depth analysis of the two phases of phenotype data along with the
genotype data to understand gene-gene and gene-environment interactions and also infer causal factors using
Mendelian Randomization based approaches. Moreover, using this dataset, we intend to use a combination of
existing and novel approaches to generate disease risk models in the ~12,000 participants and validate some
of the predictions using the longitudinal data that will be generated in the next phase of the AWI-Gen study.
Finally, using an in-depth comparison of the distribution genetic variants of disease and pharmacogenomics
relevance in African populations we aim to provide insights that could inform precision public health approach
at the level of individual participants as well as the level of the population.
!